Viral subversion of intercellular coupling during myocarditis

SUMMARY
Cardiovascular disease remains the principal cause of death in the United States, with myocarditis contributing
to 42% of all sudden deaths in young adults. Human adenovirus type 5 is a leading etiological agent of viral
myocarditis, yet research is lacking due to host species specificity limiting the development of model systems
for cardiac infection. The effect of active adenoviral infection on cardiomyocyte function and arrhythmogenesis
that precedes immune responses and progression to heart failure is unknown. Gap junctions, predominantly
comprising the protein connexin43 (Cx43) in the ventricular intercalated disc, facilitate action potential
propagation during each heartbeat. An intimate association and interplay between gap junctions, other ID
resident ion channels, and components of mechanical junctions is now well accepted. Alterations in ID
mechanical and electrical coupling cause arrhythmias, and while it has been demonstrated that adenovirus
directly targets adhesion late in infection, the relationship between adenoviral myocarditis and Cx43 gap
junction, or other ion channel, function and regulation remains unexplored. Indeed, treatment for viral
myocarditis is largely supportive, with no therapeutic interventions or antivirals demonstrating significant clinical
efficacy to date. Through study of adenoviral infection of cardiac muscle at the molecular level, we will address
significant gaps in the knowledge regarding mechanisms underlying the impact of infection on cardiomyocyte
intercellular coupling and electrophysiology while identifying therapeutic targets to limit viral spread and/or
rescue electrical coupling in diseased hearts. Our long term goal is to elucidate the pathological mechanisms
of viral myocarditis and resulting arrhythmogenic subversion of cardiac ion channels and junctional structures.
The objective of this R01 proposal is to determine how electrical and mechanical intercellular coupling is
affected during acute adenoviral cardiac infection to precipitate an arrhythmogenic substrate. Our central
hypothesis is that adenovirus hijacks junction protein expression and function leading to an arrhythmogenic
substrate prior to gross pathological remodeling and the appreciable host immune responses. We will test this
hypothesis with the following two Specific Aims: Aim 1: Determine the role of early adenoviral proteins in
generation of an arrhythmogenic cellular landscape. The working hypothesis for this aim is that early
adenoviral proteins activate a PI3K/β-catenin signaling axis targeting Cx43 and cardiac ion channel function,
contributing to arrhythmogenesis. Aim 2: Determine the role of connexins and gap junction intercellular
communication in adenoviral pathogenesis. The working hypothesis for this aim is that adenovirus
stabilizes cellular junctions to facilitate viral spread while limiting intercellular communication to enhance viral
replication.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease remains the leading cause of death in the United States, with myocarditis contributing to 42% of all sudden deaths in young adults annually, yet the relationship between viral infection and fatal arrhythmias is unknown. Our research reveals that cardiac cellular junctional structures, essential for normal electrical activity in the heart, are targeted during infection to facilitate viral replication and spread. This research will identify mechanisms underlying viral sudden cardiac death and mechanisms of arrhythmogenic ion channel remodeling, and will reveal therapeutic targets applicable not just to myocarditis, but also to the broad array of heart diseases involving deadly disruption of cardiac intercellular communication.